DOUBLE BLIND PLACEBO CONTROLLED TRIAL OF RISPERIDONE IN TOURETTE'S SYNDROME

The primary purpose of this investigation is to assess the efficacy and safety of risperidone in the treatment of Tourette Syndrome (TS) through a randomized, double-blind placebo-controlled, parallel groups study.